PET DETECTION OF THE DIABETIC HEART

IDDM patients will be admitted the CRC on three occasions overnight to stablize BG. Tests of myocardial perfusion, structure and metabolism will be performed the following day.